Project 2

Summary/Abstract
SMARCA4-mutant NSCLC represents a prevalent, aggressive subset in urgent need of effective therapies.
SMARCA4 encodes BRG1, a key ATPase subunit of the SWItch/Sucrose Non-Fermentable (SWI/SNF)
chromatin remodeling complex. SMARCA4 mutations are present in 9-11% of patients with NSCLC, with
truncating, BRG1-inactivating mutations comprising greater than one-third of these alterations. Thus, SMARCA4
is one of the most frequently mutated genes in NSCLC that has no targeted treatment option. SMARCA4
mutations often overlap with molecular alterations (KEAP1 and STK11 mutations) that decrease sensitivity to
traditional therapeutic approaches such as immunotherapy and chemotherapy. In a recent study from the Kim
laboratory, BRG1 deficiency increased DNA replicative stress and enhanced sensitivity to ATR pathway
inhibition in preclinical lung cancer models. Ataxia telangectasia mutated and Rad3-related (ATR) kinase is a
key regulator of cellular response to replication stress that activates the DNA damage checkpoint in response to
single strand DNA created during the resection of DNA double-strand breaks or due to defects in DNA replication.
Here, we will test the hypothesis that the underlying replication stress associated with BRG1 deficiency provides
a therapeutic opportunity for SMARCA4 mutant lung cancer; we will identify drug combinations effective with
ATR inhibition. We will build upon our discoveries by (Aim 1) comprehensively characterizing hallmarks of
replication stress and assessing immune system activation in NSCLC clinical specimens with SMARCA4
mutations, (Aim 2) evaluating sensitivity of SMARCA4-mutant NSCLCs to therapies targeting replication stress
defects, and (Aim 3) performing pre-clinical studies to assess the anti-tumor effects of ATR inhibition in
combination with anti-PD1/PD-L1 immunotherapy. We will leverage existing preclinical models of SMARCA4-
mutant, BRG1-deficient NSCLC generated in the Kim Lab (CRISPR-generated isogenic BRG1-deficient lines,
GEMM) and Hata Lab (BRG1-deficient patient-derived xenograft (PDX)), together with patient samples from Drs.
Dagogo-Jack and Cheng to evaluate the antitumor activity of rational combinations of candidate drugs to support
future development of clinical trials. Overall, the studies proposed in this grant aim to advance the care of patients
with SMARCA4-mutant NSCLC by exploring a novel, promising approach that exploits a unique vulnerability
induced by BRG1 deficiency. We envision that the work proposed in this study will inform clinical trials exploring
novel combination therapy approaches (ATR inhibition plus immunotherapy or gemcitabine) in patients with
BRG1-deficient NSCLC, potentially paving the way for future approvals.

Public health relevance
Narrative Loss of function of the SMARCA4/BRG1 gene occurs frequently in lung cancer, yet there is no targeted therapy available for patients with this tumor genotype. Current treatment modalities for these patients are usually ineffective, resulting in death of approximately 16,000 individuals this year in the United States alone. This work will define new precision medicine opportunities for these patients and define how targeting replication stress contributes to therapy response, which will be informative in a wide variety of cancers.